A Molecular Recognition Guidebook for Targeting Protein Loops with Covalent Ligands

PROJECT SUMMARY
Often considered simple connectors, protein loops are extraordinarily important structures, regulating essential
biological functions by forming macromolecular interactions and initiating signaling cascades. When mutated,
loops propagate cellular dysfunction and disease, transcending a multitude of infectious, hereditary, and
physiological disorders. Despite their importance, we have a limited understanding of loop structures as well as
how loops alter protein structure, activity, and allosteric communication. Historically, a powerful tool to elucidate
such structure-function relationships has been small molecules. In the pursuit of drug discovery, several covalent
ligands have been serendipitously discovered to target cysteine residues in loops, leading to potent and selective
small molecule probes. However, there is little emphasis on understanding the molecular, biophysical, and/or
structural basis of the observed selectivity; and thus, scientists are limited in extrapolating these discoveries to
target novel loop structures. In our current work, we have utilized covalent ligands to build structure-affinity
relationships for two unique protein loops, which have revealed the key role of i) ligand shape in loop recognition
and differential regulation of protein activity; ii) small molecule feature diversity in predicting covalent bond
formation to loops; and iii) loop motion in the rate of covalent bond formation.
Building upon these observations, we identified an exceptional model system to systematically study small
molecule:loop interactions. As one of the most abundant human protein domains, RNA Recognition Motifs
(RRMs) have a well-defined globular fold, loops that orthosterically and allosterically regulate RNA binding, and
> 125 cysteines in loop structures for covalent bond formation. Utilizing RRMs, this proposal will elucidate guiding
principles that describe ligand and loop features critical for i) molecular recognition, ii) regulating protein activity
and structure, and iii) altering orthosteric and allosteric communication. These first-in-kind principles can be
harnessed to rationally design small molecule modulators of novel loop structures. As current state-of-the-art is
limited to massive screening campaigns and/or serendipity, a rational approach to loop targeting will be
paradigm-shifting for chemical probe and therapeutic discovery. Furthermore, ligands discovered for RRM
domains will transform our fundamental understanding of disease; approximately 25% of disease-annotated
mutations are in RNA-binding proteins, which are an intractable, underprivileged protein class ripe for innovative
small molecule discovery strategies. In the future, we expect these principles to guide the targeting of other
dynamic and/or disordered structures, such as interdomain-linkers and intrinsically disordered regions, that when
selectively targeted, expands protein ligandability to encompass the entire human proteome.

Public health relevance
PROJECT NARRATIVE Protein loops are essential regulators of biological function and when mutated, propagate cellular dysfunction and disease. In this proposal, we will elucidate molecular recognition principles that describe how covalent small molecules form selective interactions with loops and alter their structure and activity. These first-in-kind principles will lay the foundation for the rational design of small molecule modulators of loop structures, which will vastly expand our ligandable proteome and lead to paradigm-shifting chemical probe and therapeutic discoveries.